SYNTHESIS AND DISTRIBUTION OF OPIOID AND RELATED PEPTIDES. PERIOD OF PERFORMANCE: 02/15/2017-02/14/2022. N01DA-17-7795.

Synthesis and Distribution of Opioid and Related Peptides. Task Order 7 and TO 8 (POP: May 15, 2020 through May 14, 2021)